Physical activity intervention co-created and pilot tested with African American Colorectal Cancer Survivors

Project Summary/Abstract
The long-term objective of this research is to improve physical activity among populations experiencing cancer
disparities. The goal of this training award is to: (1) deliver a multicomponent, culturally-targeted, technology-
delivered, scalable intervention to increase physical activity among African American colorectal cancer
survivors; while advancing the development of a new investigator, with a program of research focused on
increasing physical activity and decreasing cancer disparities. Specific aims are to: (1) co-create, with AA CRC
survivors who engaged in physical activity throughout cancer treatment, culturally targeted narrative videos to
increase physical activity knowledge, self-efficacy, outcome expectations, habits and enjoyment; (2) pilot test
the intervention to assess reach, effectiveness, adoption, implementation, and maintenance and; and (3)
measure outcomes at baseline, 3- and 9-months post baseline. Outcomes include: psychosocial constructs
related to physical activity engagement (knowledge, self-efficacy, outcome expectations, enjoyment, habits);
physical activity (average daily steps, weekly minutes of moderate-vigorous intensity activity); symptoms (pain,
fatigue, depression, bowel dysfunction); and inflammation biomarkers that may explain the pathways through
which physical activity impacts cancer outcomes. First, a qualitative exploratory approach will be used to
interview 20 African American colorectal cancer survivors. Together with a subset of interested participants a
multi-component intervention to increase physical activity among African American colorectal cancer survivors
will be created. Next, an additional 72 participants will be recruited to conduct a pilot two-group, randomized
repeated measures study to assess Reach, Effectiveness, Adoption, Implementation and Maintenance (RE-
AIM) of the intervention. Feasibility of collecting survey and biomarker data at baseline, 3 and 9 months later
will be assessed. These timepoints will facilitate exploration of changes pre- and post-intervention, and to
determine if effects are maintained 6 months after completing the intervention and chemotherapy. Time since
last chemotherapy will be controlled for in all analyses to account for variations in treatment schedules.

Public health relevance
Project Narrative The purpose of this research is to improve quality of life for historically marginalized cancer survivors by increasing physical activity. A culturally targeted intervention that is feasible to implement in the cancer care system will be co-developed and tested with African American cancer survivors. The project will serve as a foundation for intervening with other historically marginalized cancer survivors.